Uncovering Druggable Allosteric Sites in HCN Channels

ABSTRACT
Infantile epileptic encephalopathy (IEE) is a severe form of early-onset epilepsy and has been associated with
de novo and inherited mutations in HCN1 (hyperpolarization-activated and cyclic-nucleotide gated) channels.
Current drugs available to treat IEE are nonspecific. To create specific pharmaceuticals for IEE, disease-related
polymorphisms have been cataloged and pathology has been attributed to aberrant trafficking to the cellular
membrane or alteration of gating properties of HCN1 channels. The overall goal of this application is to develop
a novel targeted approach to uncover druggable HCN1 allosteric sites using genomic, functional, and structural
approaches. We propose to utilize both an allosteric inhibitor and an allosteric activator of HCN1 to uncover their
mechanism of action by structural determination of complexes and investigation of their functional effects on WT
and mutant channels. We will then determine the association of allosteric trajectories predicted by coevolution
models with the mechanisms of action of these small molecules as well as pathogenic mutations in HCN1.
Together with determining structures of other gating states, this will allow generation of a model of ion channel
allostery and will provide a testable framework for structure-function relationships. Allosteric modulation of HCN
channels will thus be predicted and exploited for rational design of candidate therapeutics. Our first and second
specific aims are to determine the structures by single-particle cryo-EM of HCN1 in complex with an allosteric
inhibitor, propofol, and in complex with an allosteric activator, PIP2, respectively. The candidate binding sites will
be validated by mutagenesis followed by electrophysiology. Clues into the molecular reasons for the HCN1
selectivity for propofol despite strong sequence conservation across all HCN family members, will be provided
by a bioinformatic co-evolution analysis. Statistical coupling analysis will identify and predict HCN1 allosteric
pathways and we will determine their association with pathogenic missense mutations and propofol binding.
Candidate positions will be tested by mutagenesis and electrophysiology. Our third specific aim is to obtain
structures of distinct conformers of HCN1 channels by adjusting the sample conditions (e.g. liposomes with an
established electrochemical gradient) as well as by targeting disease-associated HCN1 polymorphisms. This
aim will not only aid in understanding the basics of channel gating by determining physiologically-relevant
channel conformations, but also will facilitate structure-based drug design to modulate aberrant, disease-specific
ion channel activity.

Public health relevance
NARRATIVE The proposed research is geared towards discovering novel druggable sites on a physiologically important ion channel to treat neurological conditions such as infantile epileptic encephalopathy, which is a severe form of early-onset epilepsy. We will apply novel and established techniques and approaches towards determining the binding sites and the mechanisms of action of known allosteric inhibitors and activators, which will help us understand how these molecules affect these channels. The insight we gain into the basic mechanism of this important class of channels will also enable the design and discovery of novel therapeutics that specifically target the channels responsible for these disease conditions.